CORE--PATIENT COORDINATION AND ASSESSMENT

The purpose of the Patient Coordination and Assessment Core Module (PCACM-CORE B) is to facilitate the participation of human subjects in Program Project research, in particular, Projects I and II. Specific aims are as follows: Aim 1: To provide assessment, eligibility determination, and enrollment of potential participants into Project 1 (neurobehavioral project) and Project II (neuroimaging project); Aim 2: To recruit potential participants for the Program project, while maintaining and expanding liaison with community agencies such as parent groups, mental health agencies, and schools, in order to increase the participant recruitment base for this program of research; Aim 3: Maintain participant enrollment in the Program project and prevent attrition. Aim 4: Collect clinical data for comparison with data from Projects I and II; Aim 5: Provide culturally-based translation of parent-report measures to allow participation of children from Spanish-speaking families and other minority individuals in protocols. The PCACM will serve as a central mechanism for the management of all aspects of human subjects' participation including screening, enrollment, scheduling, transitions between projects, problem resolution, and oversight of informed consent and human subjects protection.